Phase 2 Kp-10 in Patients with Hypogonadotropic Hypogonadism

PROJECT ABSTRACT
Patients with idiopathic hypogonadotropic hypogonadism (IHH) have insufficient GnRH secretion. The lack of
endogenous GnRH leads to absent LH and FSH, resulting in suppression of ovarian and testicular function and
decreased levels of estradiol and testosterone. The neuropeptide kisspeptin is a powerful stimulus for GnRH
induced LH secretion. The goal of this study is to explore the effects of pulsatile kisspeptin to stimulate the
hypothalamic GnRH neurons of patients with HH. Thus, this application, if funded, can facilitate the translation
of this therapeutic potential to the clinic.

Public health relevance
PROJECT NARRATIVE Idiopathic hypogonadotropic hypogonadism (IHH) is a rare reproductive disorder in which patients do not go through pubertal development and remain sexually infantile and infertile if left untreated. IHH is thought to be due to the deficiency of a hypothalamic hormone called GnRH. This application explores the use of exogenous pulsatile kisspeptin administration as a novel therapy for men and women with IHH.